Promoting health by understanding the dynamic interplay between internalizing symptoms and substance use among Latinx youth in rural and small-town communities in the United States

This application is a supplement to the Latinx Health in Rural Areas project (R01DA048827) that applies
prevention science paradigm to examine etiology of substance use and related individual, family, and
community risk and protective factors among rural Latinx adolescents and young adults. The supplement will
extend the parent project into the area of mental health and examine the dynamic interplay between
depression and anxiety and substance use over the course of adolescence and young adulthood among rural
Latinx youth, an underserved and marginalized population that has grown rapidly in recent years. The long-
term career goal of the candidate, Ms. Griselda Martinez, is to become an independent investigator that
integrates developmental models of substance misuse and factors that promote health equity in this
population. The primary objective of this supplement is to understand the developmental links between
substance use and mental health using a cultural-developmental lens to inform potential prevention and
intervention targets and their timing. These objectives will be accomplished in two specific aims that: (1)
examine the reciprocal and longitudinal associations between depressive symptoms and substance use over
the course of adolescence, and the extent to which there are differences in these associations between rural
Latinx youth from immigrant vs. U.S.-born (3rd gen) families and between 3rd generation rural Latinx youth and
non-Latinx Whites. Sex differences, externalizing symptomatology, and risk and protective factors from multiple
domains will be tested. For instance, family-level factors, including family bonding and family conflict that may
change with acculturation will be examined. (2) Examine links between internalizing symptomatology
(depression and anxiety) and substance use in young adulthood and determine the extent to which there are
differences in the comparison groups of interest. Systemic barriers such as lack of access to healthcare will
also be examined. The candidate will conduct the research under the supervision of Dr. Katarina
Guttmannova, PhD, and the parent grant’s team of Co-Is across three multidisciplinary sites to gain expertise
in developmental models of substance misuse beyond alcohol and health disparities research, deepen her
proficiency with longitudinal methodologies, and lay groundwork for future independent research funding.
Training activities include mentorship meetings, advanced statistics seminars, consultation with leading
researchers on etiology of substance misuse and related health risk behaviors, and grant writing. This
supplement will allow the candidate to dedicate her time to the proposed activities aimed at establishing
independence as an investigator, which will thereby increase the number of underrepresented research faculty
conducting research in the field of drug abuse research.

Public health relevance
PROJECT NARRATIVE This project leverages over a decade of NIH-funded data collection that has yielded rich community-based longitudinal data to examine the dynamic associations between substance use and mental health across adolescence and young adulthood among rural Latinx youth, a growing and understudied population. The project will apply a cultural-developmental perspective and assess the role of risk and protective factors from multiple developmental domains – including family and community – in the interplay between trajectories of substance use and internalizing symptomatology. The findings will inform targets and developmental timing for prevention and intervention efforts aimed at reducing harms from substance use and promoting health equity.